Trained immunity in the prevention of viral myocarditis and pancreatitis

PROJECT SUMMARY/ABSTRACT
Enteroviruses, such as group B Coxsackieviruses, are common suspects in myocarditis and pancreatitis.
However, no vaccines are currently available for these viruses, in part because multiple serotypes of
Coxsackieviruses can induce similar diseases. Thus, exploration of alternative strategies to protect against
them may have merit. The research team has made an unexpected observation that animals immunized with
complete Freund’s adjuvant (CFA) were completely protected from both myocarditis and pancreatitis induced
with Coxsackievirus B3 (CVB) pointed to a possibility that trained immunity may be an underlying mechanism
of CFA-mediated effects, as demonstrated with the Bacillus Calmette-Guérin (BCG). The long-term goal of
this research is to identify adjuvants that induce trained immunity to enhance anti-viral vaccine responses in
the prevention of enteroviral infections. The objective of this application is to determine if macrophages
primed with CFA mediate trained immunity. The central hypothesis is that the CFA contributes to the
induction of anti-viral responses by trained immunity. This hypothesis will be tested by two specific aims: 1)
characterize anti-viral responses in animals immunized with CFA and 2) determine the mechanisms of CFA-
mediated protection in CVB infection. Methods and tools to be used include multiplex cytokine bead array,
virus neutralization test, and major histocompatibility complex class II dextramers to assess antigen-specific
immune responses and chromatin immunoprecipitation and metabolite assays to investigate the mechanisms
of CFA-induced trained immunity. The project is innovative because it aims to determine whether trained
immunity offers protection against CVB infections. The proposed studies are significant because they will: 1)
mechanistically investigate whether trained immunity is sufficient to prevent enterovirus infections and 2)
identify pathways that contribute to CFA-induced trained immunity. These outcomes may have a significant
impact on strategies for preventing and/or treating viral infections using mycobacterial components that are
known to possess immune-stimulating properties.

Public health relevance
PROJECT NARRATIVE The proposed research has relevance to public health because it will address whether naturally trained immunity induced by the complete Freund’s adjuvant containing mycobacterial substance is sufficient to prevent enterovirus infections that commonly affect the heart and pancreas. This research is relevant to the mission of NIH because proving this concept to be true may allow us to use bacterial components in future vaccine studies, which would aid significantly in preventing viral infections.